Administrative Core

Project Summary/Abstract, Administrative Core (Core A)
The proposed program project aims to close research gaps in antiretroviral treatment for pregnant women and
infants living with HIV with four inter-related projects and two supportive cores. The size of the program; the
number of collaborators and participating institutions; and the planned sharing of personnel, resources, and data
between projects will require skilled project management, coordination, and financial oversight for efficiency and
success. The Administrative Core will provide project management for the overall program, foster strong
collaboration between partners, maintain communications between researchers and with external stakeholders,
implement work processes to efficiently and cost-effectively achieve program goals, monitor research progress
and redirect resources as needed, manage regulatory requirements, and provide financial management.